Sleep Quality and Mechanisms of Cardiovascular Risk in Adults with Hypertension

R01 Brief Project Summary
Sleep Quality and Mechanisms of Cardiovascular Risk in Adults with Hypertension
The objective of the study is to elucidate the potential mechanisms responsible for the increased risk of CVD
among patients with hypertension and comorbid insomnia. To address this issue, we propose to utilize a
behavioral intervention to manipulate sleep quality in 150 adults with hypertension and comorbid insomnia, who
will receive a 6-week Cognitive Behavioral Therapy for Insomnia (CBT-I) intervention, which has been shown to
markedly improve sleep quality and promote consolidated sleep in approximately 60% of those treated. Blunted
nighttime blood pressure dipping is one of several proposed mechanisms to be examined.

Public health relevance
PROJECT SUMMARY / ABSTRACT Insomnia is a sleep disorder that has become increasingly recognized as a cardiovascular disease (CVD) risk factor which is linked to both the presence of hypertension and incident hypertension. However, the mechanisms linking insomnia to hypertension and increased CVD risk are not understood. The objective of this application is to elucidate the potential mechanisms responsible for the increased risk of CVD among patients with hypertension and comorbid insomnia. To address this issue, we propose to utilize a behavioral intervention to manipulate sleep quality in 150 adults with hypertension and comorbid insomnia. All participants will receive an established 6-week Cognitive Behavioral Therapy for Insomnia (CBT-I) intervention, which has been shown to markedly improve sleep quality and promote consolidated sleep in approximately 60% of those treated; whereas approximately 40% do not respond to CBT-I. This generally effective, but nonetheless variable treatment response will provide the prerequisite range in sleep quality changes that will afford us the opportunity to identify the putative mechanisms by which improved sleep may lower CVD risk. Sleep quality will be assessed using a multi-modal assessment strategy, including structured interview, self-report, and objectively by wrist-actigraphy. The proposed study design includes a 6-week, run-in period, without treatment, to document the stability of sleep quality, The overarching strategy is to identify the candidate mechanisms linking sleep to CVD risk according to whether they exhibit changes that are correlated with the changes in sleep quality following CBT-I. Blunted nighttime blood pressure (BP) dipping is characteristic of 30-40% of patients with hypertension, and is associated with both subjective and objective measures of poor sleep quality, as well as with insomnia. Therefore, the proposed study includes a focus on nighttime BP and nighttime BP dipping, as assessed by 24-hour ambulatory BP monitoring. There is also evidence to suggest that several other bio-behavioral mechanisms may be important, including nighttime sympathetic nervous system (SNS) activity, vascular endothelial function, arterial stiffness, and lipid profile. The outcome of the study is expected to be of high impact by identifying key mechanisms whereby poor sleep quality exacerbates CVD risk in the context of hypertension, and by determining whether these mechanisms may be modifiable with treatment.